Spreading Depolarizations and Neuronal Vulnerability

PROJECT SUMMARY
This project addresses mechanisms that underlie the progression of acute brain injuries, including stroke and
trauma. Our long-term goal is to inform interventions that can be applied at delayed time points, and ultimately
translated to clinical studies to improve survival and quality of life of survivors. Our project is focused on the
phenomenon of spreading depolarization (SD). Recent clinical data have provided exciting evidence that clusters
of SD waves cause progression of damage for many days in stroke and trauma patients. During the last funding
period, we made progress in understanding how bursts of glutamate release during SD can lead to injury, and
our work has led to initial clinical testing of pharmacologic approaches to block SD. However, these interventions
still require sedation of patients, so alternative approaches are needed. In addition, the clinical situation is
complex, since beneficial effects of SD could contribute to survival or recovery of peri-infarct tissues. An
important challenge now is to understand whether and how SD may have beneficial effects, and whether the
balance between detrimental and beneficial effects of SD can be shifted. This project uses brain slices and
animal models to identify fundamental mechanisms that underlie beneficial effects of SD, and approaches to
support compromised tissues to recover from repeated SD episodes. Our central hypothesis is that the balance
between detrimental and beneficial effects of SD is determined by the metabolic competence of the brain tissue
that it invades. We propose that bouts of SD produce both short and long-term adaptation in metabolically
competent tissue. We will test whether these adaptations have significant consequences on brain recovery, and
whether providing improved metabolic support or selective targeting of deleterious consequences of SD can
significantly improve outcomes. Specific Aim 1 tests the hypothesis that SD activates short-term protective
mechanisms, which take effect over seconds to minutes, and can be exploited to support neuronal survival during
SD clusters. Studies in brain slices will examine protective diffusible factors generated by SD and by support
with metabolic substrates. Specific Aim 2 tests the hypothesis that SD activates beneficial pathways that promote
neuronal protection, recovery, and repair over hours to days. A focal stroke model will be used to: a) test whether
invasion of SD into surviving peri-infarct tissues can promote survival, and b) identify pathways that inhibit
neuronal death pathways and enhance mechanisms required for remodeling (over days to weeks). Specific Aim
3 tests the hypothesis that the balance between damaging and beneficial effects of SD can be shifted by
modifying either the recovery from individual SD events or long-term adaptive processes. Successful completion
of these aims will yield insights essential for future refinements and improved treatments for stroke and other
acute brain injuries.

Public health relevance
PROJECT NARRATIVE This project addresses fundamental mechanisms that contribute to the progression of acute brain injuries, focusing on waves of neuronal activation that occur repetitively following injury onset. We will identify mechanisms underlying the balance between detrimental and beneficial effects of these waves, providing the basis for improved experimental designs for preclinical and clinical trials.